Haemophilus influenzae lipoprotein fusion vaccine and lipoprotein vaccine platform development

Abstract: A vaccine to prevent Nontypeable Haemophilus influenzae (NTHi) infections is
a major unmet need. NTHi causes respiratory infections in children and adults including acute
otitis media (AOM), acute sinusitis, conjunctivitis, acute exacerbations of chronic obstructive
pulmonary disease (COPD), neutrophilic asthma and invasive disease that leads to high morbidity
and mortality worldwide. Previously we have shown lipidation of proteins P6 and OMP26 of NTHi
enhances antibody and Th17 immunity and provides protection against nasopharyngeal (NP)
colonization and ear infection caused by NTHi compared to non-lipidated constructs. In this
project, we will evaluate immunogenicity and protective efficacy of NTHi lipidated protein D and
protein F and their fusion constructs versus their non-lipidated constructs after systemic
vaccination in a mouse model of NP colonization, ear and lung infection. We expect our novel
lipidated and fusion constructs to enhance serum and mucosal IgG antibody and activate Th17-
mediated immunity in nasal associated lymphoid tissue (NALT) along with generating T-cell
resident memory (TRM) against NTHi. Differential effects of diacyl vs triacyl variation of a lipid
moiety in stimulation of TLR2/TLR1 vs. TLR2/TLR6 will be determined. We have synthesized and
will test a quadrivalent (L-OMP26φNL-P6φNL-PDφNL-PF) fusion (truncated version of each
proteins based on their functional epitopes) making only one protein lipidated anticipating
enhanced immunogenicity for all 4 proteins. Overall the project will expand our understanding of
immune mechanisms activated by novel lipoprotein NTHi fusion vaccine constructs and identify
any differences in immune response associated with diacyl vs. triacyl lipidation (TLR2/TLR1 vs.
TLR2/TLR6 activation) on protective efficacy against NTHi NP colonization, ear and lung infection.
This project will more broadly innovate with a novel lipoprotein vaccine platform that may be
applied to other pathogens and vaccine candidate proteins (including those that are not naturally
lipidated) where mucosal colonization is the first step of pathogenesis.

Public health relevance
Project Narrative. In this project, we will evaluate immunogenicity and protective efficacy of novel NTHi lipidated protein D and protein F and their fusion constructs, a 90% pure diacyl vs 90% pure triacyl L-PDφNL-PF lipoprotein fusion construct, and a quadrivalent (L- OMP26φNL-P6φNL-PDφNL-PF) truncated protein fusion construct versus their non-lipidated constructs after subcutaneous vaccination in a mouse model of NP colonization, ear and lung infection. Serum and mucosal IgG antibody, activation of Th17-mediated immunity in nasal associated lymphoid tissue (NALT) generation of T-cell resident memory (TRM) against NTHi will be assessed. Differential effects of diacylated vs triacylated variation of a lipid moiety in stimulation of TLR2/TLR1 vs. TLR2/TLR6 will be determined.